Imaging Assessments of ARPKD Kidney Disease Progression

Modified Project Summary/Abstract Section Autosomal Recessive Polycystic Kidney Disease (ARPKD) is a potentially lethal inherited disorder that affects approximately 1/20,000 children and is associated with significant morbidity and mortality; only 70% of ARPKD children survive the neonatal period and 40% progress to end- stage kidney disease by age 15 years. There are currently no disease-specific, clinically-available therapies for ARPKD and treatment is directed at management of chronic kidney disease complications. Several novel therapies have, however, shown promise in both ARPKD animal models and adult autosomal dominant PKD (ADPKD) patients. Unfortunately, the major roadblock for implementing clinical trials in ARPKD patients is the absence of sensitive measures of ARPKD kidney disease progression. Conventional measures of kidney disease progression, e.g., declines in estimated glomerular filtration rate (eGFR), are variable in ARPKD and GFR may remain unchanged despite ongoing kidney damage. Imaging assessments of kidney volume, which have been successfully utilized in ADPKD clinical trials, have limited applicability to ARPKD, as kidney size stabilizes over time despite worsening cystic disease. Therefore, alternative markers are needed to stage and monitor ARPKD kidney disease progression. Our multidisciplinary imaging team has identified T2-MRI as a sensitive measure of ARPKD progression. In studies in ARPKD animal models, we utilized high resolution T2-MRI to establish renal cystic burden as an accurate and sensitive marker for ARPKD progression and therapeutic response. In preliminary studies in ARPKD patients, we showed increased mean kidney T2-MRI values in comparison to healthy controls, with mean T2 values variations consistent with differences in kidney disease severity. Our team has also pioneered novel Magnetic Resonance Fingerprinting (MRF) technologies that are resistant to motion artifacts and allow for rapid, simultaneous acquisition of multiple imaging parameters. The overall objective of this project is to establish mean kidney T2 values as a sensitive, quantitative MRI biomarker to stage and longitudinally monitor ARPKD kidney disease. We will utilize these techniques to obtain both cross-sectional and longitudinal assessments of kidney disease in pediatric and young adult ARPKD patients recruited from across the U.S. The proposed studies will be the first to systematically apply these quantitative MRI techniques to assess renal cystic burden in ARPKD patients, with the long-term goal of developing MRI biomarkers for ARPKD kidney disease that can be used to identify patients at high risk for disease progression and to serve as outcome measures for eventual clinical trials for ARPKD patients.

Public health relevance
Modified Public Health Relevance Section Autosomal Recessive Polycystic Kidney Disease (ARPKD) is a potentially lethal inherited kidney disease affecting children and young adults. Importantly, there are currently no disease-specific clinically-available therapies for ARPKD patients, and clinical trials of potential new therapies are severely limited by the lack of accurate and sensitive measures of kidney disease progression in ARPKD patients. In this proposal, we will evaluate the capability of quantitative T2-MRI and novel MR Fingerprinting technologies to provide a safe, sensitive measure of ARPKD progression that can eventually be used in future clinical trials.